CORE--DATA MANAGEMENT AND BIOSTATISTICS CORE

This Center has evolved an integrated system of data management and statistical analysis of PET imaging data. During the past four years we have organized our activities into three cycles supporting data collection, data processing and management, and data quality control and statistical analysis. The primary aim of this Core is to continue to provide support for the collection, processing and management of the data required for proposed and current PET imaging projects. In practical terms, we will 1) monitor and track patient enrollment and studies, assist with data collection activities and maintain data flow management; 2)provide accurate data entry and data validation and editing; and 3) provide project investigators and statisticians with analyzable data files. A second aim is to develop statistical procedures to detect global and regional changes in cerebral blood flow (CBF) stimulated by activation probes. Differences in CBF between baseline and language activation conditions have been investigated through the mixed-model and the fixed effects factorial analysis of variance (ANOVA). Our preliminary data analyses have shown promise for detecting activation - baseline effects, although the test for interaction effects to identify the specific RoIs affected by specific probes may require a more subtle and sensitive approach than the ANOVA. To describe expected distributions of changes in CBF (that is, normal repeat study variability under resting conditions) for any two studies and specific locations we propose an experimental study of four resting "baseline" PET 15H2O scans in normal subjects of the same gender, age and neurological and circulatory health.